RELATIONSHIPS BETWEEN NEGATIVE SYMPTOMS, DEPRESSION, AND SOCIAL COGNITION

Depression is often observed in patients with schizophrenia. It is not clear, however, that these patients are aware of depressed behavior. The observation of depression in schizophrenic patients also engenders the question of the role of blunted affect as a negative symptom. The role of blunted affect as a negative symptom, and the affect as a negative symptom, and the patient's awareness of depressed behavior is not clear. Therefore, understanding relationships among depression, negative symptoms, and social cognition has both clinical and neurological implications. A completed study demonstrated an association between negative symptoms, observer-rated depression,and current social skills. The purpose of the current project is to determine if self-rating depression, scales completed by chronic mentally ill patients are clinically valid. Concurrently, the study also investigates relationships among rater-observed depressed affect, self-reported depression, negative symptoms, premorbid social and affective histories, and current levels of social skills.